The Emory Healthy Brain Study: Discovering Predictive Biomarkers for Alzheimer's Disease

Abstract/Summary
Progress in understanding Alzheimer’s disease and related disorders (ADRD) is close to producing more
effective treatments, creating an urgent need for disease-predictive biomarkers to guide their use. Using
cerebrospinal fluid (CSF) measurements of beta-amyloid and Tau and positron-emission tomography tracers,
we can detect AD pathology in cognitively normal individuals. However, current tools do not allow us to predict
when or even if an individual with asymptomatic pathology will develop symptoms. To address this need, we
propose to longitudinally study ≥3000 cognitively normal individuals (50-75 years at enrollment) in the Emory
Healthy Brain Study to define the frequency of asymptomatic AD and rates of cognitive decline in a racially
diverse cohort of healthy individuals (Specific Aim 1). An important goal of Aim 1 is to achieve ≥33% African-
American participants to provide sufficient power to address questions regarding race- and sex-dependent
differences in biomarkers and risk of cognitive decline. Participants will be phenotyped biennially with cognitive
testing, cardiovascular physiology, brain MRI, and blood and CSF collection. Cross-sectional (Specific Aim 2)
and longitudinal analyses (Specific Aim 3) will test the hypothesis that biomarkers of synaptic, vascular,
myelination, glial immunity, and metabolic functions will identify subgroups who are at greatest risk of
progressing to symptomatic AD. Candidate biomarkers will be identified through state-of-the-art proteomics,
MR imaging, and statistical methods. A highly collaborative data and biospecimen sharing plan will allow other
investigators to leverage these resources to advance a broad spectrum of ADRD research.

Public health relevance
Project Narrative Recent advances in Alzheimer’s research has highlighted the need for preventing disease rather than treating symptoms. As we get closer to achieving effective treatments, there is an urgent need for tools that will allow us to identify individuals at risk of developing disease in order to deliver appropriate interventions. The Emory Healthy Brain Study will follow a large (≥3000) and racially diverse (1/3 African-American) group of healthy 50- to 75-year-old individuals over time with collection and analysis of blood, cerebrospinal fluid, and brain MRI scans to develop predictive tests to guide preventive treatments.